Administrative Core

CCMI v2.0
Administrative Core
Core Leads: Nevan Krogan and Trey Ideker
SUMMARY
The mission of the Administrative Core is to promote the scientific and outreach goals of the Cancer Cell Map
Initiative (CCMI) v2.0 and to connect the CCMI to the broader cancer systems biology community and the NCI.
Amongst its responsibilities the Core will perform the following: serve as the primary contact for all internal
logistical and organizational aspects of the CCMI; serve as the primary contact for external interactions with
other centers in the Cancer Systems Biology Consortium (CSBC), the NCI, and the cancer research community;
implement strategies to enhance diversity and inclusion in cancer systems biology; manage the solicitation,
review, and funding of Research Center pilot projects; and ensure timely sharing of data and resources produced
by all Research Center Projects and Cores through the U24 Coordinating Center and NIH/NCI resources. Day-
to-day activities will be coordinated by a cross-campus team consisting of the Co-Directors, Assistant Director,
Research Center Administrators and Data Managers. The Core will organize a Steering Committee to evaluate
the progress and needs of each CCMI component, review and possibly modify priorities, and identify areas
deserving of extra focus. To facilitate communication amongst Center members, the Core will organize a variety
of regularly scheduled meetings, some specifically for members of the Steering Committee and others for the
entire CCMI. The Core will also facilitate communication with the CSBC and NCI, especially around key events
such as the CSBC Annual Meeting, the Junior Investigators’ Meeting and the various CSBC Working Groups.
To enhance diversity and inclusion in cancer systems biology, the Core will ensure that opportunities are
provided to a diverse set of researchers, whether that opportunity is to present at a CCMI-organized event or as
a recipient of CCMI research funds. The Core will also manage the solicitation, review, and funding of pilot
projects of faculty members wishing to develop and apply systems biology approaches to address a compelling
biomedical question in cancer in collaboration with CCMI investigators. Finally, to ensure the timely sharing of
data and resources, we have designated two qualified Data Managers, one in San Francisco with experimental
expertise and one in San Diego with computational expertise, who will interact with the consortium to facilitate
the timely sharing of interoperable datasets and community accessible resources. In addition, the CCMI web
portal will be maintained as a collaborative effort among the Administrative Core, Outreach Core and
Software Infrastructure for Network Models and Cell Maps Core (Core 2). It provides researchers with a
central access point for CCMI networks and cell maps; custom websites in support of CCMI publications;
and a catalog of software tools, tutorials and links to documentation.